Aging in Community Health Clinics: Multimorbidity Patterns among Middle-Aged and Older Adults (ACHES)

Project Summary
Multimorbidity among older adults is prevalent, disabling, and costly. Vulnerable adults may be at even greater
risk of multimorbidity earlier in the lifespan and may also experience sequelae and additional diagnoses that
increase multimorbidity burden over time. Greater understanding of how disease patterns change over time
and putative interactions with individual and community-level factors motivates the current proposed project
that centers on the health of vulnerable adults. This work will advance the field of multimorbidity and aging in
important ways by addressing key gaps in knowledge: (1) What kinds of multimorbidity patterns are most
common among patients seeking care in community health centers (CHCs) and how do these patterns change
over time? (2) Do community-level factors moderate the association between multimorbidity and poor health
outcomes for CHC patients? (3) Do middle-aged and older adults seeking care in CHC settings demonstrate
more rapid age-related declines (e.g., greater burden of multimorbidity, complex patterns of multimorbidity)
compared to their non-CHC health care seeking peers? And, (4) How do health care needs and utilization
change for middle-aged and older adults with multimorbidity? Our proposed research leverages clinical
electronic health record (EHR) data from large networks of CHCs and non-CHCs. We anticipate important
insights from findings that will inform clinical processes (workflow, clinical care decision-making) and policies
that serve safety-net populations by identifying multimorbidity patterns predictive of rapid health downturns. We
propose three aims to:
Aim 1. Identify the prevalence, patterns, and health outcomes associated with specific multimorbidity
combinations for middle-aged and older CHC patients over time and by sociodemographic factors.
Aim 2. Identify community-level social determinants of health that moderate the relationship between
multimorbidity combinations and disease progression, exacerbations, and mortality among middle-aged
and older CHC patients.
Aim 3. Specify multimorbidity prevalence and patterns over time among middle-aged and older adults
seeking care in CHC relative to matched counterparts seeking care in non-CHC settings.

Public health relevance
Project Narrative This project examines the number and type of chronic conditions vulnerable adults are living with and identifies adults most at risk for worsened symptoms, escalation of chronic disease-related problems, and additional diagnoses that are accumulated over time. The proposed work will inform intervention programs for adults in the safety-net. By identifying disease combinations that are most predictive of complications, intensive use of health care services, and death, future work can test best practices and delivery models that are more attuned to the needs of individuals with the most challenging combinations of chronic disease.